Para-hydrogen induced polarization of 13C labeled TCA cycle metabolite precursors

Abstract
In vivo 13C MRS/MRI offers the unique opportunity to observe various metabolic processes in real time as they
happen when enabled by a hyperpolarization technique. The most common technique for hyperpolarization is
dissolution Dynamic Nuclear Polarization (DNP). DNP works by enhancing the NMR signal via the microwave-
driven polarization transfer from electrons to target nuclei. While dissolution DNP-NMR can produce dramatically
enhanced liquid state NMR signals, it has severe limitations including expensive hardware, the need for a free
radical polarizing agent, extended polarization build-up time at cryogenic temperatures and batch-wise operation.
An alternative technique for 13C hyperpolarization is para-hydrogen induced polarization (PHIP), which involves
the chemical addition of para-hydrogen (hydrogen gas enriched in the para spin isomer) to unsaturated
substrates followed by the conversion of the singlet spin order of the para-H2 into 13C spin polarization by
magnetic field cycling. Although PHIP requires specific chemistry, the advantages of PHIP over DNP make this
technique very appealing: it is far less expensive, faster and capable of the large-scale production of
hyperpolarized samples, potentially in a continuous flow manner. In this exploratory project we will develop
innovative chemistries (13C-enriched, unsaturated precursors to important metabolites and novel catalyst
systems) that will significantly widen the scope of PHIP for 13C metabolic studies. The goal of Aim 1 is the
synthesis and PHIP of 13C-labeled, unsaturated precursors to 2-ketoglutarate, an important intermediate of the
TCA cycle. In Aim 2, we will explore the PHIP of O-acetylated enol derivatives of 13C labeled pyruvate and
oxaloacetate. Catalytic hydrogenation of these intermediates will yield lactate and malate derivatives. A major
goal of this aim will be the development of chiral catalyst systems that would preferentially afford the natural L-
form of these important metabolites.

Public health relevance
Narrative In vivo 13C MRS/MRI can be used to follow various metabolic processes in real time when enabled by a hyperpolarization technique. Para-hydrogen induced polarization (PHIP) is a cost effective, fast and up-scalable technique of hyperpolarization. In this exploratory project we will develop innovative chemistries that will significantly widen the scope of PHIP for 13C metabolic studies.